IN VIVO IMAGING OF STATE-DEPENDENT ASTROCYTE VOLTAGE DYNAMICS AND NEURAL ACTIVITY IN MOUSE VISUAL CORTEX

SUMMARY
This proposal aims to fundamentally advance our understanding of astrocyte physiology by
using novel genetically encoded voltage indicators (GEVIs) to measure the coordinate of
astrocyte membrane potential (Vm) and local neural activity in vivo. Historically considered
“electrically uninteresting,” because of the minimal variations in somatic voltage observed in
patch recordings, our preliminary data with JEDI3, a sensitive, stable, two-photon compatible
GEVI, reveals robust changes in membrane voltage in vivo that track closely with variations in
neural activity and behavioral state. In Aim 1, we will characterize the spatiotemporal
coordination of astrocyte Vm fluctuations and neural activity across multiple contexts—cortical
up/down states under anesthesia, transitions between quiet wakefulness and active locomotion,
visual stimulation, and seizures—and test the extent to which these voltage changes occur
independently of astrocyte calcium signaling. In Aim 2, we will determine how neuromodulatory
inputs (noradrenergic and cholinergic) shape astrocyte Vm and whether manipulating astrocyte
voltage can influence state-dependent neuronal dynamics. We will also validate optogenetic
tools for reliably controlling astrocyte voltage, a critical advance that will enable causal tests of
the effects of manipulating astrocyte membrane voltage. In Aim 3, we will resolve subcellular
hotspots of astrocyte depolarization at the scale of individual dendrites and axons, and test
whether presynaptic activity alone is sufficient to drive these focal changes. Finally, as part of
Aim 3, we will develop and validate improved astrocyte-optimized GEVIs, ensuring that these
optical methods are made accessible to the broader neuroscience community. By illuminating
the “hidden” electrical dimension of astrocyte function, this work promises to transform our
understanding of glia-neuron interactions, reveal novel mechanisms of brain state regulation,
and open new therapeutic avenues for neurological diseases where astrocyte dysfunction is
implicated.

Public health relevance
NARRATIVE This research aims to uncover a previously overlooked electrical dimension of astrocyte function by directly measuring membrane voltage dynamics in vivo. By revealing how astrocyte voltage changes are coordinated with and impact neural activity and behavior, this work has the potential to identify new mechanisms underlying cognition and state-dependent brain disorders. Ultimately, these findings could guide the development of novel therapeutic strategies that target astrocytic electrogenic processes to alleviate neurological conditions such as epilepsy, migraine, and depression.